Aspirnaut Undergraduate Discovery Science Experience in Renal Biology and Disease

There is critical national need for educational innovations that recruit undergraduate students into STEM
(science, technology, engineering, mathematics) disciplines and increase the number of scientists who conduct
research in areas relevant to the NIH mission, particularly that of NIDDK. There is a dearth of diverse STEM-
oriented undergraduate students, those from geographically- and economically-disadvantaged backgrounds
and underrepresented racial and ethnic minority groups and who are American Indians, to recruit into STEM
careers. Moreover, shortfalls in STEM achievement in K-12 students threaten the pipeline for entry of STEM
undergraduates into advanced studies and the STEM workforce.
To address these challenges, we established a novel initiative in 2009, called the Aspirnaut™ K-20 STEM
Pipeline for Diversity (www.aspirnaut.org), at Vanderbilt University Medical Center (VUMC). The overarching
goal was to develop a model to elevate STEM achievement and increase the number and diversity of students
that entered the STEM workforce. The Aspirnaut™ initiative was enabled by a 2-year NIDDK grant, awarded
under the auspices of the American Recovery and Reinvestment Act (ARRA). The trainee outcome and
research program served as the Pilot Data for a NIDDK R25 grant that was awarded to us in 2012 that paved
the way to establish the “Aspirnaut Discovery Science Experience in Renal Biology and Disease.”
In this renewal, we propose to leverage our success to further increase the number of diverse
undergraduate students that pursue STEM careers relevant to the NIDDK mission. We will implement several
mentoring innovations, piloted over the previous funding cycle, to perfect a holistic model of discovery science
experiences augmented with professional skills development and guided self-discovery. The specific aims are:
Aim 1. To recruit 40% of participants from underrepresented racial and ethnic groups and American Indians
and 70% from geographically- and/or economically-disadvantaged backgrounds and/or limited family level of
education.
Aim 2. To engage 10 undergraduate students per year in a research experience on the topic of “Renal Biology
and Disease”
Aim 3. To augment the discovery science experience with professional skills development and guided self-
discovery.
The anticipated outcomes will establish a holistic model for recruiting and increasing the number and
diversity of undergraduates entering STEM disciplines of relevance to the NIDDK mission.
.

Public health relevance
There is a critical national need for educational innovations that recruit undergraduate students to pursue STEM (science, technology, engineering, mathematics) disciplines that fill the pipeline with scientists who conduct research in areas relevant to the NIH mission, and, in particular, that of NIDDK. In this renewal, we propose to leverage our success in recruiting, preparing and increasing the numbers of diverse undergraduate students that pursue STEM careers relevant to the NIDDK mission. Additionally, we will implement several innovations, piloted over the previous funding cycle, to perfect a holistic model of research experiences augmented with professional skills development and guided self-discovery. .